Genetic and Signaling Mechanisms in the Central Regulation of Blood

Overall Summary
The central nervous system (CNS) plays a major role in obesity and hypertension but the knowledge of the
neural circuits controlling physiological pathways regulating blood pressure, feeding, and energy expenditure
remain limited. The long term goal and central theme of the third competitive renewal of this program is to
identify mechanisms and neural circuitry regulating blood pressure and energy homeostasis in hypertension
and common obesity. Many of these mechanisms are shared among blood pressure and metabolic neural
control circuits but differentially control physiological endpoints by virtue of their location in the CNS and the
cellular pathways engaged. We will examine molecular mechanisms operating in the forebrain and
hypothalamus which alter the hypertensive response to cardiovascular and metabolic stressors, the
mechanisms regulating renin-angiotensin system (RAS) activity and its relationship with arterial pressure and
metabolic function, mechanisms regulating the trafficking and function of critical receptors regulating
cardiovascular and metabolic functions, and the intracellular signals that differentially control resting metabolic
rate and arterial pressure. Project 1 will test the hypothesis that forebrain leptin receptors and microglial
activation in the neural network controlling sympathetic tone and body energy metabolism play a fundamental
role in sensitization of the hypertensive response which is mediated by activation of N-Methyl-D-aspartate
receptors. Project 2 will test the hypotheses that the coordinated expression of renin-a and renin-b in the
subfornical organ (SFO), paraventricular nucleus (PVN), and arcuate nucleus (ARC) mediates local
angiotensin-II (ANG) production and action to control autonomic output and thus cardiovascular and metabolic
endpoints; and that disinhibition of renin-a expression with concomitant inhibition of renin-b expression in the
SFO, PVN and ARC is required to mediate sensitization of the hypertensive response to mild humoral and
dietary stressors. Project 3 will test the hypotheses that dysfunction a protein complex, the BBSome, in the
contributes to common diet-induced obesity and to obesity-associated hypertension and sympathetic nerve
activation by a) altering the cellular processes underling the trafficking of the receptors that regulate energy
homeostasis and blood pressure, and b) by interfering with the firing activity of ARC proopiomelanocortin
neurons. Project 4 will test the hypothesis that ANG acts at AT1 receptors on AgRP neurons of the ARC to
activate a regulator of G-protein signaling-2 (RGS2)-sensitive Gαi second-messenger cascade, which controls
AgRP production and thus modulates melanocortin signaling, ultimately to control thermogenic SNA and
resting metabolism. These projects are synergistic both conceptually and technically and will collectively
advance our understanding of the basic molecular and cellular that underlie neural control of cardiovascular
and metabolic functions in health and disease. Insights gained from our integrated proposed program can pave
the way for novel therapeutic approaches for the treatment of to hypertension and obesity.

Public health relevance
Overall Narrative The incidence of obesity and hypertension has reached epidemic proportions in the United States, which will have serious consequences for the well-being of all Americans from both health and economic perspectives. The goal and central theme of this program is to examine fundamental mechanisms and neural circuitry regulating arterial blood pressure and energy homeostasis in hypertension and common diet-induced obesity. Insights gained from our integrated proposed program will provide critical insight into the molecular perturbations that contribute to hypertension and obesity.